REGULATION OF CARBOHYDRATE METABOLISM IN CEREBROMICROVASCULAR CULTURES

The regulation of norepinephrine induced glycogenolysis has been investigated in cultured cerebromicrovascular cellular elements. Preliminary studies revealed that the glycogenolytic effect of norepinephrine can be partially prevented by Beta2-adrenergic blockers in endothelial cultures.